Pilot Project Core

PILOT PROJECT CORE ABSTRACT
The goal of the Native Center for Alcohol Research and Education (NCARE) is to nurture innovative research
on health inequities among American Indians and Alaska Natives (AI/ANs) due to alcohol use disorders (AUDs),
including their prevention, diagnosis, treatment, and consequences across the lifespan. One critical strategy for
achieving this goal is to fund pilot projects that will develop novel approaches to improving AI/AN population
health. Pilot projects provide a way to seed emerging research areas, explore new methodologies, and pursue
new regional and national collaborations that could evolve into independently funded research or demonstration
projects. Existing university-based options for pilot funding provide limited sums (e.g., $5,000-$10,000) that are
often inadequate to conduct community-based research and are typically restricted to investigators at the home
institution. The Pilot Project Core of NCARE is designed to identify and allocate substantial funding to support
pilot projects that rigorously test practices, treatments, educational efforts, and policies that can effect sustained,
widespread reductions in AI/AN health disparities due to AUDs. We will recruit a broad range of investigators
from NCARE and outside institutions who can begin or augment their research with support from the Pilot Project
Core. Given serious concerns about the aging of the scientific workforce funded by the National Institutes of
Health, and the equally worrisome dearth of minority Principal Investigators, we will encourage applications from
junior faculty and AI/AN investigators. The Pilot Project Core will offer myriad possibilities for research, including
but not limited to studies of the etiology, biology, genetics, diagnosis, treatment, and prevention of AUDs and
their biomedical, psychosocial, and economic consequences. Our Specific Aims are to: 1) Create a Pilot Project
Core to fund innovative Pilot Projects with meaningful implications for AUDs and related health inequities in
AI/AN communities; 2) Use the scientific review process as a learning opportunity for junior investigators and
NCARE members who desire reviewing experience; and 3) Develop centralized research services that support
the investigators who lead NCARE Pilot Projects, including junior investigators with a strong interest in alcohol
research. We will also leverage our successful experience with other small grant programs to offer financial,
logistical, and scientific resources to researchers whose proposals meet our rigorous criteria. By creating a
centralized research support service and allocating substantial financial resources for NCARE Pilot Projects, this
approach will foster an ecosystem of innovative and rigorous research. The activities of the Pilot Project Core
will support investigators nationwide, thereby contributing to the development of new scientific methods,
technologies, and approaches pertinent to innovative, goal-directed AUD research on a national scale.